Regulation of Chlamydial Divisome Assembly

The obligate intracellular pathogen Chlamydia trachomatis is the leading bacterial cause of sexually
transmitted infections. This coccoid, gram-negative bacterium does not encode several proteins essential for
binary fission including FtsZ, the major regulator of binary fission in most bacteria, and we previously showed
that Chlamydia divides by a polarized budding process. Our data indicate that chlamydial budding is driven by
a novel hybrid division machinery that contains elements of the divisome (FtsK, PBP3) and elongasome (MreB,
MreC, and PBP2) machinery defined in other bacterial systems. However, many questions regarding the
mechanisms that regulate this polarized division process remain unanswered. Two of the most interesting
questions are how the site of polarized budding is defined in this coccoid organism, and how do MreB, MreC,
and PBP2 function with elements of the divisome to drive polarized budding. Although Chlamydia does not
encode several proteins essential for binary fission, it expresses FtsK, a DNA translocase that accumulates at
the septum of bacteria where it couples the segregation of replicated chromosomes to the septation of
daughter cells during division. The translocase activity of FtsK is dependent upon the recognition of specific
DNA sequences (KOPS sites) by the γ domain at the C-terminus of the protein. The γ domain of FtsK also
interacts with XerD and activates XerCD-dependent recombination at dif sites near the chromosomal terminus,
which is required for the decatenation of chromosomal dimers that arise during replication to monomers to
enable their segregation. We show here that FtsK in Chlamydia accumulates in two foci in budding cells, one
at the septum of the dividing cell and one at the base of the progenitor mother cell. This pattern of localization
was also observed for PBP2, PBP3, MreB, and MreC suggesting these proteins function as part of a divisome
complex that coordinates chromosomal segregation with septation during division. Our data suggest that the
proteins that accumulate at the base of the mother cell correspond to an immature divisome complex where
the bud will emerge in the next round of division, and FtsK initiates the assembly of immature divisomes by
associating with XerD bound to the chromosomal dif site. The studies described in this proposal will test the
novel hypothesis that the site of divisome assembly in Chlamydia is specified by the binding of FtsK to XerD
that is associated with the chromosomal dif site. In addition, we will test the hypothesis that interactions
between elongasome and divisome components of the hybrid division machinery of Chlamydia are critical for
divisome assembly and the recruitment of MreB to the complex activates peptidoglycan synthesis required for
polarized budding. Our proposed studies will be significant as they will be the first to define the molecular
mechanisms that regulate divisome function in an organism that lacks FtsZ. In addition, defining the
mechanisms associated with the novel polarized division process of Chlamydia may lead to the development
of specific therapeutics for eliminating chlamydial genital tract infections in humans.

Public health relevance
The obligate intracellular pathogen Chlamydia trachomatis is the leading bacterial cause of sexually transmitted infections with an estimated 20 million cases occurring annually in the United States. Our results indicate that this organism utilizes a novel polarized mechanism to divide within infected cells. By defining the key features of this unique cell division process we will be able to develop new therapeutic approaches for specifically eliminating chlamydial genital tract infections in humans.